Chitin and chitinases in SARS-CoV-2 infection

ABSTRACT
Severe Acute Respiratory Syndrome Coronavirus 2 (SARS-CoV-2) and resultant coronavirus disease 2019
(COVID-19) has caused a global health crisis, surpassing 100 million infections in the United States. SARS-
CoV-2 infections range from asymptomatic to respiratory failure and death, and can result in an array of long-
term effects collectively referred to as post-acute sequelae of SARS-CoV-2 infection (PASC). The
pathobiological mechanisms and environmental factors underlying the intensity and duration of these effects
remain unclear, but a range of chronic lung impairments that resemble complications associated with age-related
pulmonary fibrosis have been documented in severe COVID-19, suggesting that environmental drivers
implicated in pulmonary fibrosis may also influence the course of SARS-CoV-2 infection and PASC. We have
identified the environmental constituent chitin as a candidate environmental driver of persistent SARS-CoV-2-
induced disease, consistent with its previously described role in pulmonary fibrosis. Our preliminary studies show
that chitin spontaneously accumulates in the lungs of SARS-CoV-2-infected mice, and is accompanied by
alterations in the expression patterns of the major lung chitinase, AMCase, suggesting that chitin-chitinase
interactions may contribute to SARS-CoV-2 pathogenesis. In comparison with wild-type (WT) controls, mice that
genetically lack AMCase exhibit exacerbated lung pathology after infection with SARS-CoV-2, implicating chitin
and chitinases in the pathologic sequelae that occur during the recovery phase. Thus, we hypothesize that
environmental chitin can drive COVID-19 severity, epithelial dysregulation, and disease persistence, and that
epithelial chitinases attenuate this process by degrading chitin. In this project, we leverage recently developed
mouse models of SARS-CoV-2 infection and chitin exposure to delineate a host-environmental interaction that
may contribute to persistent lung impairments following SARS-CoV-2 infection. We will test our hypothesis by
addressing two Aims: (1) determine the influence of environmental chitin on the severity and persistence of lung
pathology after SARS-CoV-2 infection, and (2) define the role of mammalian chitinases in SARS-CoV-2 infection
and persistent lung disease. Understanding how environmental chitin influences long-lasting pathologic
responses after SARS-CoV-2 infection may lead to the identification of new biomarkers and therapeutic targets
associated with differential disease outcomes in COVID-19 and PASC.

Public health relevance
PROJECT NARRATIVE This project explores the effect of chitin, a widespread environmental polysaccharide, on the post-acute sequelae (PASC) of Severe Acute Respiratory Syndrome Coronavirus 2 (SARS-CoV-2) infection. Since chitin is normally degraded by chitinases present in the airways of mice and humans, we will characterize chitinase-producing epithelial cells in mouse models of SARS-CoV-2 infection, and test whether altering chitinase activity influences the severity and persistence of disease induced by SARS-CoV-2 infection. Understanding how environmental chitin influences long-lasting pathology after SARS-CoV-2 infection may lead to the identification of new biomarkers and therapeutic targets associated with PASC and differential COVID-19 disease outcomes.